Administrative Core

PROJECT SUMMARY/ ABSTRACT – ADMINISTRATIVE CORE
The goal of the Administrative Core of the Cancer Research and Education to Advance HealTh Equity
(CREATE) Partnership is to provide strategic leadership and administrative oversight to advance the
overarching goal of the Partnership. This includes providing an efficient infrastructure to support all scientific,
administrative, and fiscal activities of the Partnership to ensure effective synergy within and across San Diego
State University (SDSU) and the UC San Diego (UCSD) Moores Cancer Center (MCC). Additional goals
include developing cancer research opportunities and pathways for undergraduate, graduate, and medical
students as well as early-stage investigators (ESIs), which will lead to a future workforce that is more diverse
and reflective of the catchment-area population. As a single unit, the Administrative Core provides strategic
leadership and administrative oversight to advance Partnership goals. The Core is the glue that keeps the
Partnership together, and due to its extensive experience and history, it is able to provide necessary services
to support an efficient administrative system and infrastructure under the leadership of multiple Principal
Investigators. The Administrative Core is structured so that the Partnership leaders can establish and
implement a highly integrated operation that ensures exponential benefit from the collaboration of the two
institutions. The Core works synergistically to effectively implement the CREATE Partnership activities in
cancer research, research education, early-stage faculty career development, and community outreach. To
accomplish Partnership goals, the CREATE leadership proposes the following Specific Aims: 1) Provide
leadership, coordination, and management to the scientific, administrative, and fiscal components of the
CREATE Partnership. 2) Promote evidence-based and sustainable interactions and build new research
collaborations across the Partnership. 3) Procure scientific and strategic feedback and guidance from internal
and external advisors. 4) Assist in recruitment of ESIs and work with the Transforming fAcuLty dEvelopmeNT
for Equity (TALENT) Shared Resource to support their career development. The AC is positioned to build
strong institutional commitment to cancer research and cancer disparities research, while growing the
Partnership’s research education programs and increasing outreach to the communities and their providers in
the Southern Border Region of California. By the end of this project period, the Partnership intends to grow the
cancer research base at SDSU by at least 25% and the number of peer reviewed funded cancer disparities
and/or community-engaged grants by at least 20%.